Targeting cell state transitions driving resistance to KRAS inhibitors in lung cancer

Lung adenocarcinoma (LUAD), commonly driven by KRAS mutations, is responsible for 7% of all cancer
mortality. LUAD predominantly arises from alveolar type 2 (AT2) cells, which function as facultative alveolar stem
cells by self-renewing and replacing alveolar type 1 (AT1) cells. The first allele-specific KRAS inhibitors (KRASi)
were recently approved in LUAD, but clinical benefit is limited by intrinsic and acquired resistance. Histologic
transformation of LUAD to squamous cell cancer (adenosquamous transition, AST) has been reported as a form
of acquired resistance to KRASi. Such cancer cell state transitions are emerging as central mechanisms of
resistance to oncologic therapies. Importantly, they are not associated with acquired genetic events but are
driven by epigenetic reprogramming and transcriptional re-wiring of cellular differentiation programs. To meet
the challenge of treatment resistance in the clinic, identifying and targeting cell states that confer resistance to
KRAS inhibitors must be sought with urgency. We used genetically engineered mouse models, patient-derived
xenografts and organoids, and patient samples to identify LUAD differentiation states that drive resistance to
KRASi. We found KRASi promote a quiescent AT1-like cancer cell state in LUAD tumors. The AT1-like LUAD
cells exhibit high growth potential upon treatment cessation, whereas ablation of the AT1-like cells sensitizes
tumors to KRASi and robustly improves treatment response. Notably, targeting KRAS in LUAD tumors harboring
mutations in STK11, encoding the LKB1 tumor suppressor, invariably leads to histologic transformation into AST
that is resistant to KRASi. These findings implicate genetically deterministic differentiation programs as key
drivers of resistance to KRASi in lung cancer, whereby LKB1-proficient cancer cells adopt an AT1-like state and
LKB1-deficient cells undergo a squamous transformation. We hypothesize targeting either the AT1-like or the
squamous transition state, informed by LKB1status, will overcome resistance to KRASi in LUAD. To address
this hypothesis, we will (i) investigate the origin and fate of the alveolar/squamous states in tumors using lineage-
tracing; (ii) model outcomes of cytoablative therapies targeting the AT1-like/squamous states utilizing lineage-
ablation; (iii) uncover molecular cell state drivers and evaluate them as targets in the context of LKB1 proficiency
or deficiency. To do this, we will take advantage of novel genetically engineered mouse models (GEMMs) of
KRAS(G12D) or KRAS(G12C) mutant LUAD that we have developed. We validate our findings in human patient-
derived tissues and xenografts. Our proposed study will allow us to establish the AT1-like and squamous
transition states (i) as LKB1 genotype-specific biomarkers of intrinsic resistance and relapse potential in LUAD
and (ii) as targets for cytoablative therapies to overcome resistance to KRASi, as well as to identify molecular
drivers of these cell states. Thus, this work will elucidate novel cellular and molecular mechanisms of response
to KRAS-targeted therapy and inform strategies to overcome treatment resistance in LUAD patients.

Public health relevance
PROJECT NARRATIVE The first allele-specific KRAS inhibitors were recently approved in lung adenocarcinoma (LUAD), but clinical benefit is limited by intrinsic and acquired resistance. We hypothesize resistance to KRAS inhibitors is driven by cancer cell differentiation into AT1-like or squamous states, which is determined by LKB1 proficiency or deficiency, respectively. Here, we interrogate the function and molecular drivers of the AT1-like and squamous transition states, which we hope would lead to new therapeutic strategies overcoming resistance to KRAS inhibitors in LUAD patients.